Spectral flow cytometry identifies new immune signatures that provide personalized ALS risk and progression biomarkers and therapeutic targets

ABSTRACT
Amyotrophic lateral sclerosis (ALS) is a progressive motor neuron disease with no cure, and although
inflammation plays a significant role in the disease, gaps remain in leveraging this knowledge for personalized
clinical outcome models and personalized therapeutics. Peripheral blood immune profiles—defined as the total
numbers and activation states of specific peripheral immune cells—reflect overall inflammation, but
methodologic gaps exist to characterize these immune profiles given limitations in conventional flow cytometry,
hampering its widespread use for ALS. The long-term goal is to leverage immune profiles to identify
dysregulated immune pathways that can be treated to slow or stop ALS progression. The overall objective in
this proposal, being submitted in response to RFA-TS-25-036 Funding Option A, is to establish spectral flow
cytometry as the state-of-the-art approach to characterize peripheral immune profiles in ALS. The central
hypothesis is that spectral flow cytometry will yield rigor and reproducibility with fresh and frozen blood
samples and will identify pro-inflammatory immune profiles for ALS clinical outcome prediction. The rationale is
that establishing rigorous protocols for the widespread multicenter use of spectral flow cytometry in ALS will
unlock the complex, but vast, potential of the immune system for improving diagnosis, prognosis, and drug
development for all persons with ALS. The central hypothesis will be tested by pursuing two specific aims: 1)
Utilize spectral flow cytometry to quantify inflammation in ALS peripheral blood biosamples and determine the
consistency of immune markers between samples processed fresh versus frozen to inform multisite ALS
studies; and 2) Determine the natural history, diagnostic, and prognostic significance of comprehensive
longitudinal spectral flow cytometry immune profiles as an ALS inflammatory signature. Under the first Aim,
spectral flow cytometry protocols will be optimized to characterize ALS inflammation in fresh and frozen
samples, paving the way for its use in multisite ALS studies. Under the second Aim, immune profiles will be
associated with important ALS clinical outcomes, such as case status and disease progression. The research
proposed in this application is innovative, in the applicant’s opinion, because it moves the field in a new
direction—bridging both mechanistic and knowledge gaps—by bringing the transformational potential of
spectral flow cytometry to ALS, establishing the rigor needed to make the technology widely available to the
ALS community, leveraging the resulting data to better understand the role of comprehensive immune profiles
for ALS, and providing the foundation for future multisite studies. The proposed research is significant because
peripheral blood immunophenotyping will enable improved ALS clinical outcome associations, and eventually
therapeutic target identification, testing, and responder analysis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on using the latest advanced technology to identify the alterations in the immune system that impact amyotrophic lateral sclerosis (ALS) in a rigorous and reproducible manner that is amenable to multi-site application. The findings will not only enhance understanding of the role of the immune system in ALS, but also greatly advance efforts to develop diagnostic strategies, identify relevant biomarkers and therapeutic targets, and establish treatment approaches for persons with ALS based on therapies that mediate immune function. Thus, the proposed research is relevant to the CDC’s mission that pertains to protecting the health of the American people by developing the fundamental knowledge about the factors that contribute to ALS and developing the tools needed to facilitate insights into risk, prognosis, and treatment targets for ALS.